Role of Beta Spectrin and Smad in Alcohol Induced Liver and GI Cell Proliferation

ABSTRACT
Alcohol-induced liver damage remains a major health issue. From the previous funding cycle, we determined
that mice with impaired signaling through the transforming growth factor β (TGF-β) pathway, that depends on
Smad3 and the Smad adaptor β2 spectrin (β2SP, Sptbn1) phenocopy Beckwith-Wiedemann Syndrome
(BWS). Interestingly, BWS is a human stem cell disorder that is associated with severe developmental
abnormalities and liver disease characterized by steatosis, chronic hepatitis, inflammation, and neoplasia.
TGF-β deficient mice (Sptbn1+/-, Sptbn1+/-Smad3+/-) had altered function of the chromatin organizing protein
CTCF (CCCTC-binding factor), a protein that we found also binds Smad3 and β2SP. These TGF-β mutant
mice also had reduced expression of FancD2, encoding a protein involved in DNA repair, and increased
expression of genes associated with stem cells, such as ALDH, encoding aldehyde dehydrogenase, and
TERT, encoding the catalytic subunit of telomerase. Moreover, the TGF-β mutant mice were deficient in repair
of DNA crosslinking damage. The TGF-β mutant mice are highly sensitive to the toxic effects of alcohol, and
develop liver cancers.
Therefore, we hypothesize that the inflammation and liver injury in the TGF-β deficient mice result from altered
impaired CTCF function that together with Smad3 and β2SP defect, impair expression of key genes involved in
DNA repair (FancD2) and stem cell homeostasis, and that these mice will be susceptible to alcohol-induced
liver inflammation, injury, and cancer. To explore these hypotheses, we will test mechanisms by which the
tripartite complex of CTCF, Smad3 and β2SP regulates FancD2 expression, stem cell homeostasis in the liver,
and the response to alcohol-induced liver injury.
To explore roles for FancD2 in stem cell homeostasis, we will investigate the relationship between this TGF-β
pathway and FancD2 in liver cells positive for the stem cell marker CD133 (also known as Prom1) from our
TGF-β deficient mice (Sptbn1+/-, Sptbn1+/-Smad3+/-), as well as in vivo studies with our mice that have already
been engineered to have inducible impairment of the pathway. This application will enable studies that provide
new understanding into stem cell-driven responses to alcohol in the liver, which will provide insights into
treating various types of not only alcohol-induced liver injury but liver diseases associated with inflammatory
responses.

Public health relevance
PROJECT NARRATIVE Our goal is elucidate mechanism for imbalances generated from loss of TGF-β signaling, in genetic and environmental factors (including agents such as alcohol), that lead to deregulation of liver inflammation and injury. Our TGF-β deficient mutants of the Smad3 adaptor β2SP are highly sensitive to alcohol, with dysregulation of Fanconi anemia (FA) member FancD2, loss of function of CTCF (CCCTC-binding factor) (a DNA-binding protein that regulates higher-order chromatin organization), as well as stem cell molecules such as ALDH. This dysregulation from loss of TGF-β signaling contributes to decreased protection from DNA damage, response to injury and disruption of stem cell homeostasis, that we propose to provide a better understanding of in this application.